FUture Surgeons and Scientists Investigating ONcology

Project Summary
The FUture Surgeons and Scientists Investigating ONcology (FUSSION) YES program at the University of
Alabama at Birmingham (UAB) is designed to increase interest in cancer-related research among college
students from groups who are underrepresented in biomedical sciences, with the goal of creating a pipeline of
diverse future physician-scientists with cancer-related research programs. To achieve this goal, FUSSION will
provide a 2-year mentored research experience augmented by monthly workshops on cancer-related topics,
scientific communication, and career and academic development. The NCI Youth Enjoy Science program
provides an ideal avenue to achieve the following specific aims: SPECIFIC AIM 1: Provide cancer-related
research experiences for undergraduate students with mentoring from successful physician-scientists.
To achieve this aim, students will participate in a 2-year experience on cancer-related issues, mentored by
scientists and physician-scientists, including two consecutive summers of full-time, research with dedicated
scientists. SPECIFIC AIM 2: Establish a curriculum that provides a foundational understanding of a
variety of cancers, research-related knowledge, responsible conduct of research, professional and
career development skills, academic development, and dissemination of research results. Students will
receive instruction on foundational and clinical cancer topics, along with training in scientific communication,
career development, and academic preparation to enter graduate and medical school. SPECIFIC AIM 3:
Expand awareness of current cancer research and the importance of the FUSSION program by
integrating outreach opportunities into students’ research dissemination strategies. Students will
disseminate their research to the UAB campus and wider communities: at a departmental research event, a
campus symposium that family and friends can attend, and to the community through an outreach panel
discussion. Participants will share the knowledge and experiences gained and the impact it has had on their
understanding of cancer, with an emphasis on the importance of research in addressing cancer prevention,
treatment, and disparities. The FUSSION project is unique in its focus on physician-scientists. To our
knowledge, no other YES program has a specific focus on physicians as a part of cancer research. Given
UAB’s exceptional success in research and training, and the Department of Surgery’s experience developing
similar research and training programs, UAB is well positioned to implement such a program. Moreover,
because one-quarter of the Alabama population is African-American, UAB offers a unique population to
investigate cancer-related disparities and minority health. There is a great need for more physicians who are
also researchers, in order to translate scientific discoveries to the bedside. Increasing the number and diversity
of physician-scientists can directly impact patient diagnosis, treatment, and outcomes to mitigate health
disparities.

Public health relevance
Narrative There is a great need to increase the number and diversity of physician-scientists, who are uniquely positioned to translate cancer-related scientific discoveries directly to patients. This program seeks to increase the number and diversity of physician-scientists who are committed to investigative excellence in cancer-related research by providing early 2-year training experiences for undergraduate students.